Mayo Clinic Center for Clinical and Translational Science (CCaTS)

Mayo Clinic is one of the largest not‐for‐profit, academic health systems, top-ranked for quality more often than any other health care organization. It has integrated operations in 5 U.S. states, and more than 1 million people came to Mayo Clinic for care last year. Clinical and translational science (CTS) is a fundamental and highly valued element of Mayo Clinic; indeed, all research at Mayo Clinic is directed towards translation of scientific knowledge to improve patient care, with almost 60% of our NIH funding base classified as clinical research or trials. In recognition of the importance of continued advances in CTS to the Mayo Clinic mission, our institutional leadership has entrusted the Mayo Clinic Center for Clinical and Translational Sciences (CCaTS) to be the engine of translational innovation and the institutional advocate for CTS and translational research. CCaTS has served as a CTS innovation incubator for numerous efforts that were created with CCaTS funding and are now supported by the institution. The overall vision of CCaTS is to enable high-quality, team-based multidisciplinary research that accelerates clinical trial innovation, facilitates digital health transformation, and partners with our stakeholders and communities to improve patient care and health for all people. Our team-based culture has been described as one of “boundarylessness,” wherein organizational barriers are removed to enable talent, innovation, and knowledge to converge where needed. In this context and that of our longstanding commitment to patient-focused research, we are uniquely positioned to accomplish the following Specific Aims. In Aim 1, we will simplify and accelerate the work of translation to improve health for all by advancing clinical trial innovations and digital health transformations, streamlining methods and processes, and developing novel informatics solutions that increase efficiency and drive implementation of discoveries that improve health and promote health for all. In Aim 2, we will enhance our education programs through the expanded reach of competency-based, learner-focused solutions, training a multidisciplinary CTS workforce to be prepared to address the urgent health care needs of all communities in a rapidly changing environment. In Aim 3, we will engage local community members and patients to be active partners in translational teams, expanding research capabilities of communities, including rural populations. Our goal is to improve health by helping communities realize the benefits of CTS. In Aim 4, we will expand national and regional partnerships and strengthen collaborative CTS networks in all aspects of CTS and education, focusing on sharing innovative approaches, with the goal of improving human health and advancing health for all. In summary, sustained investment in CCaTS will enable us to continue to meet ongoing and emergent challenges in health care.

Public health relevance
The Mayo Clinic Center for Clinical and Translational Sciences (CCaTS) accelerates innovations in clinical research and partners with our stakeholders and communities to improve patient care and human health for all people. It supports scientists who bring new discoveries to clinical practice, trains a multidisciplinary workforce prepared to address the urgent health care needs of all communities in a rapidly changing environment and works closely with other research centers across the country to share innovative approaches.